Alternative Nicotine Delivery Systems as Potential Harm Reduction Tools for Persistent Cigarette Smokers

PROJECT SUMMARY
Nearly 70% of the ~ 30 million adult cigarette smokers in the US want to quit, and 55% report trying to quit at
least once in the past year - yet, over 90% fail despite using smoking cessation medication. The average smoker
will attempt to quit smoking at least 30 times before abstaining for 12 months or longer. These attempts typically
occur over decades of smoking, carcinogen and toxicant exposure, resulting in 480,000 deaths annually. Novel
alternatives must be considered to significantly reduce the combustible cigarette-attributable morbidity and
mortality among smokers unable to quit with traditional approaches. The Surgeon General’s Report and others
have underscored that helping smokers who cannot quit smoking switch to less harmful nicotine-containing
products – a harm reduction approach - can dramatically reduce this health burden. E-cigarettes (ECIGS), and
oral nicotine pouches (ONPs), expose users to few of the chemicals found in cigarette smoke and are thus
promising noncombustible harm reduction tools for smokers who would not otherwise quit smoking. For their
harm reduction potential to be realized, fundamental questions must be answered. One, can persistent
smokers switch from combustible cigarettes to either ECIGS or ONPS? Initial research suggests that one-
third of smokers fully switch to ECIGS, although comparable data is unavailable for ONPS. Two, what factors
influence switching? The factors affecting the transition to ECIGS or ONPS have yet to be investigated. Three,
does one of these noncombustible alternatives expose users to lower levels of harmful chemicals than
the other? Only limited, indirect, and industry-sponsored data exist. Documenting the relative success of
switching to ECIGS or ONPS, identifying drivers of switching, and quantifying the associated harm reduction will
inform research to optimize smokers’ success in transitioning from combustible cigarettes.
We propose the first longitudinal investigation of the substitutability of ECIGS versus ONPS for
combustible cigarette smoking, factors that impact switching, and their potential to serve as harm
reduction tools. Persistent cigarette smokers (n=200) motivated to switch from combustible cigarettes will be
randomized to a six-week regimen of ECIGS or ONPS. Baseline smoking rate will be established during days 1-
5. Laboratory visits on days 6 and 7 will assess ECIG and ONP-associated subjective reward and the reinforcing
value of either ECIGS or ONPS relative to combustible cigarettes. Participants will then switch from cigarette
smoking to ECIGS or ONPS for six weeks. The primary outcome measure is the longitudinal daily count of
cigarettes from baseline to the end of the six-week switch period and at 26 weeks follow-up (secondary endpoint).
Changes in biomarkers of potential harm, assessed at baseline and the end of the six-week switch phase, will
be secondary outcome measures. The proposed study aligns with the Notice of Special Interest (NOSI, NOT-
OD-22-023) for “studies of how ENDS use influences smoking and harm reduction studies that involve switching
from combustible cigarettes to electronic nicotine delivery systems … and alternative nicotine delivery systems.”

Public health relevance
PROJECT SUMMARY The average smoker attempts to quit smoking at least 30 times before succeeding. These attempts typically occur over decades of smoking, carcinogen and toxicant exposure. Novel alternatives must be considered to reduce the combustible cigarette-attributable morbidity and mortality among smokers unable to quit with traditional approaches.